Development of Amygdalo-Prefrontal Connections in Adolescent Macaques

PROJECT SUMMARY/ABSTRACT
This project combines the expertise of Dr. Katalin Gothard at The University of Arizona [US] and Dr. Anna W.
Roe at Zhejiang University [China]. The aim of this project is to understand changes in the brain underlying the
emergence of social and emotional regulation during adolescence. Adolescence is a period of accelerated social
and cognitive development, and also a time of enhanced vulnerability for anxiety and impulse-control disorders,
which elevate the lifelong risk for secondary psychiatric disorders. During this period, the prefrontal cortex
undergoes maturation, but little is known about the maturation of its relationship with the amygdala, considered
a hub of emotional processing in the brain. In humans and nonhuman primates, the amygdala matures long
before puberty; in early adolescence, emotional processes and arousal governed by the amygdala dominate
emotional and social behavior. As the prefrontal cortex matures and increases its influence on amygdalar
function, emotional behavior becomes more regulated. We hypothesize that the development of emotional
regulation during adolescence is due to changes in amygdala-prefrontal networks. The goal of this proposal is
to monitor longitudinally, in the same individuals, the reorganization of functional connections between the
amygdala and the PFC. This will be accomplished by a multimodal approach of laser-fMRI functional tract tracing,
and neurophysiological recordings in the amygdala and the prefrontal cortex. In parallel, punctate administration
of behavioral tasks will provide a measure of longitudinal changes in impulsivity and sociability. The fMRI,
neurophysiological, and behavioral measures will be correlated at matched timepoints, thereby achieving a
multiscale (cellular to circuit level to behavior) understanding of adolescent development. The findings from this
study will have significant bearing on our understanding of normal adolescent brain development and also of the
possible risk factors for the emergence of social misadjustment and mental disease.

Public health relevance
PROJECT NARRATIVE The aim of this project is to understand changes in the brain underlying the emergence of social and emotional regulation during adolescence. Here, we will use cutting edge neurotechnologies coupled with carefully designed behavioral assessments to study changes in connectivity between the prefrontal cortex and the amygdala during adolescence. The findings from this study will impact our understanding of adolescent brain development and the early foundations of mental disease.